DIGITAL IMAGE ANALYSIS CORE

The Digital Image Analysis core will complement the Intravital Multi-photon Microscopy Core by providing digital image processing services for O'Brien investigators to support data exploration and quantification. The Core will provide analysis services, will train investigators in the use of image analysis software and will develop new tools to enhance and extend the visualization and quantification of deep tissue microscopy images. In particular the Digital Image Analysis core will develop and distribute user-friendly software that will provide effective, efficient tools for quantifying 2-dimensional and 3-dimensional fluorescence microscopy images. These services will be made available remotely through the dissemination of free, flexible image analysis software and an interactive televisualization system. The Digital Image Analysis Core will provide researchers with powerful new tools enabling them to conduct novel studies addressing fundamental issues of renal physiology, cell biology and pathophysiology.

Public health relevance
The Indiana OBrien Center Is founded upon the mission of developing and implementing methods of microscopy that provide unique and powerful insights into renal function and dysfunction. The Digital Image Analysis Core plays a critical role in this mission, developing critical tools to explore and quantify microscopy studies.